Mechanisms of de novo membrane assembly

7. PROJECT SUMMARY/ABSTRACT
The ability to rearrange vesicular traffic to create new membrane compartments de novo is a
fundamental cell biological process important for many aspects of cellular physiology and differentiation. Two
common examples of this phenomenon are the creation of autophagosomes and the generation of the ciliary
sheath. In both cases, vesicles coalesce on a protein substrate to create a small double membrane that
subsequently expands into a distinct organelle. Defects in these processes are associated with a variety of
diseases, highlighting the importance of this aspect of cellular physiology to human health. Prospore
membrane formation during the process of sporulation in budding yeast is another example of a de novo
membrane formation event. Prospore membrane formation occurs on the microtubule organizing center of the
cells, analogous to the ciliary sheath in higher cells, and the prospore membrane expands to encapsulate
cytoplasmic components, analogous to an autophagosome. These similarities are due to parallels at the
molecular level that make yeast sporulation a powerful model system to identify the underlying molecular
mechanisms of membrane assembly. The experiments in this proposal are focused on two aspects of this
process: 1) how the MOP promotes coalescence of vesicles to create the prospore membrane, and 2) how the
Vps13 lipid transfer protein promotes membrane expansion.

Public health relevance
8. PROJECT NARRATIVE The ability to create new intracellular membrane compartments de novo is a fundamental aspect of eukaryotic cell behavior. Disruption of processes that involve de novo assembly are implicated in many pathological syndromes including ciliopathies and neurodegenerative diseases. Understanding the mechanisms of membrane assembly and expansion is therefore important for human health. The process of sporulation in budding yeast provides an excellent model in which to study de novo membrane formation. The experiments in this proposal are focused on understanding the molecular events required for initiation of a new membrane compartment on the yeast spindle pole body and how the Vps13 lipid transfer protein promotes expansion of that membrane.